Helping to End Addiction Long-term (HEAL): Induced Pluripotent Stem Cell (iPSC)-Derived Cell Types for Pain, Addiction and Overdose

Developing iPSC-derived Satellite Glial Cells for Drug Development
Peripheral neuropathy (PN) is a common cause of neuropathic pain, often requiring opioid use in a subset of patients. Although causes of PN vary, it is relatively common in patients with certain common autoimmune conditions such as Sjogren syndrome (SS) and systemic lupus erythematosus (SLE). A novel autoantibody associated with neuropathic pain and PN in Sjogrens disease patients has been identified. Notably, this autoantibody was directed against a protein in satellite glial cells (SGC) in the dorsal root ganglia (DRG). This research project will develop SGCs from human iPSCs to be used in mechanistic studies as well as a tool for screening additional patients for novel autoantigens that may play a role in neuropathic pain. Thus far SCTL has generated scRNA-Seq data from rodent DRGs to identify additional developmental markers of SGCs, which overall represents an understudied cell type. Sub-clustering analysis of the satellite glia and Schwann cell cluster identified cellular subtypes and dynamics of changes over time. Additionally, slingshot analysis revealed a plausible developmental trajectory and tradeSeq revealed the genes that drive these developmental trajectories. As of 2022, our collaborator is preparing a manuscript based on our analysis.

Testing a Reversible Gene Editing Method for Analgesia using iPSC-derived Sensory Neurons
Human genetic studies have identified new targets that are important for nociception, with the voltage-gated sodium channel, NaV1.7 (SCN9A), being perhaps the most promising candidate for analgesic drug development. Specifically, a hereditary loss-of-function mutation in NaV1.7 leads to insensitivity to pain without other neurodevelopmental alterations. However, the similarity between various NaV sodium channels presents challenges for developing nociceptor selective inhibitors. Collaborators developed targeted epigenetic repression of NaV1.7 via epigenome engineering approaches as a potential treatment for chronic pain. The current goal is to optimize epigenetic repression reagents targeting the human NaV1.7 gene in a human iPSC-derived nociceptor cell model to enable its translation into the clinic. In the past year, Navega has optimized zing finger protein (ZFP) design and SCTL has assessed the efficiency and specificity of AAV-mediated delivery of ZFPs for NaV1.7 repression in our sensory neurons.

New iPSC lines from Phelan-McDermid Syndrome Patients to Identify Novel Pain Mechanisms
Patients with Phelan-McDermid syndrome show altered pain perception but little is known about the underlying mechanisms and molecular changes. Disease-in-a-dish models utilizing iPSCs from patients with pain or addictive disorders may advance understanding of different types of pain, and differences in individual pain responses or risk of developing chronic pain or addiction upon opioid exposure. This project is generating new iPSC lines from fibroblast cell lines, which in turn were derived from skin punches obtained from 22 Phelan-McDermid syndrome and 13 controls from family members. All fibroblast cell lines are already part of the NIMH Repository study 115 and managed by Sampled (formerly Rutgers University/RUCDR Infinite Biologics). The goal is to reprogram fibroblasts into iPSC lines and then make them available for distribution, serving as a valuable resource for the scientific community. In 2022, 34 cell lines were successfully reprogrammed and banked. In April 2023, the lines were made publicly available at NIMHs biorepository. Link: https://www.nimhgenetics.org/download-tool/IPSC

Manufacturing and Functional Characterization of iPSC-derived Nociceptors and Astrocytes
Existing protocols to differentiate human nociceptors from stem cells are inefficient, take a long time, produce limited numbers of neurons which are immature and do not have the full functional repertoire or gene expression profiles of primary nociceptors. NCATS has developed a new protocol for differentiating human nociceptors from iPSCs. The protocol is highly efficient and reproducible and based on the characterization performed to date by NCATS and external collaborators, these iPSC-derived nociceptors resemble primary sensory neurons much closer than neurons generated with previously published protocols. Hence, the advanced human nociceptor platform will be used in several projects for new target identification as well as high-content and high-throughput drug screening. To date, our collaborators have performed phenotypic screening to identify compounds that selectively decrease nociceptor excitability without blocking cortical/motor neuron activity. Our collaborators have also used our iPSC-derived nociceptors to screen for protective compounds using a paclitaxel-induced neuron degeneration model of chemotherapy-induced peripheral neuropathy (CIPN). In the past year, SCTL has published a paper in collaboration with Clifford Wolf and Bruce Bean on the scalable generation of sensory neurons from iPSCs.